Role of PRKC alpha in Extracellular Matrix Remodeling

ABSTRACT OF PARENT R01
Fibrosis is the final common pathway in chronic liver disease that leads to liver failure, and is characterized by
an imbalance of extracellular matrix (ECM) deposition and remodeling. There are currently no FDA-approved
therapies to target this endpoint of chronic liver disease. Moreover, there is a paucity of biomarkers that reflect
disease-specific pathways in patients. Development of new therapeutics and biomarkers for patients with hepatic
fibrosis is a critical unmet need. Our long-term goal is to develop antifibrotic therapies for the treatment of hepatic
fibrosis and to develop biomarkers to define the patient populations that would benefit most from these therapies.
Our prior studies discovered an antifibrotic target, the enzyme acid ceramidase (aCDase). Targeting aCDase
ameliorates fibrosis by inhibiting YAP/TAZ, key effectors of the Hippo pathway, and promotes ECM remodeling.
We developed a signature score of genes downregulated by ceramide, the Ceramide Responsiveness score
(CRS), and demonstrated that the CRS is increased in patients with advanced fibrosis. Despite the fact that
targeting aCDase in HSCs ameliorates activation in culture and ablating its expression prevents liver fibrosis in
vivo, chronic ceramide accumulation may have untoward side effects. The overall objective of the proposal is to
clarify the mechanisms by which ceramide regulates YAP/TAZ, ECM remodeling, and hepatic fibrosis. We also
seek to validate the CRS as a pathway-specific biomarker in patients with hepatic fibrosis. The rationale for this
project is that understanding the mechanisms of ceramide-mediated attenuation of HSC activation and hepatic
fibrosis will offer a strong scientific framework to facilitate the development of antifibrotic therapeutics and
biomarkers for patients. To achieve this objective, this proposal has three specific aims. In specific aim 1, we will
determine the mechanism by which ceramide regulates Hippo signaling. In specific aim 2, we will characterize
how ceramide regulates ECM remodeling. Specific aims 1 and 2 will be achieved by gain of function and loss of
function techniques in vitro and testing HSC-specific knockout mice. In specific aim 3, we will analyze the
correlation between the CRS, fibrosis stage, and fibrosis progression using deidentified human liver samples,
and will identify clinical characteristics that correlate with the CRS. The mechanistic understanding to be gained
from the successful completion of the proposed studies promises to reveal new targets for rational disease
modification in hepatic fibrosis, a disease with limited treatment options available. Furthermore, by clarifying
molecular mechanisms and defining a pathway-specific signature, our work will facilitate a personalized medicine
approach for patients with hepatic fibrosis.

Public health relevance
PROJECT NARRATIVE OF PARENT GRANT The proposed research is relevant to public health because identifying the molecular mechanisms by which ceramide inactivates human hepatic stellate cells and ameliorates fibrosis will enhance our understanding of fibrogenesis and improve our ability to halt disease progression among patients with chronic liver disease. Thus, the proposed project is relevant to the NIH’s mission to seek and apply knowledge to lengthen life and reduce illness.